Defining and interrupting metabolic crosstalk in the glioblastoma microenvironment

Project Summary/Abstract
Glioblastoma (GBM) is the most common aggressive primary brain tumor and is uniformly fatal with a median
survival of only 1.5 years. Surgical resection and chemoradiation therapy are critical interventions for almost all
GBM patients and have repeatedly improved survival in multiple randomized trials. Still, almost all GBMs recur
with acquired therapeutic resistance that cannot be overcome with conventional treatments. Thus, there is an
urgent need to develop novel strategies to inhibit therapeutic resistance and improve patient outcomes.
In my work so far, I have found that metabolite levels in brain tumors inform patient survival outcome. My
work in vivo and in human clinical studies demonstrate that GBM tumors upregulate biosynthesis pathways
relative to adjacent brain tissue, rewiring cortical glucose metabolism to support pro-tumor processes. I have
also shown this metabolic activity responds to genotoxic insult and promotes therapy resistance. Thus, targeting
metabolism in GBM is an attractive therapeutic strategy, and we are now performing clinical trials to inhibit this
activity in GBM patients at the University of Michigan.
The research described in this proposal will build on these findings and define how GBMs acquire nutrients
required to grow and resist therapy. My preliminary data suggest GBMs coopt neurometabolic processes
including brain-derived production of glutamine and lactate, which are neurotransmitter precursor and metabolic
fuel. Importantly, their production (by astrocytes) and uptake (by tumors) can be intracranially blocked by
pharmacological agents but has never been tested in GBM or in combination with chemoradiation therapy.
Therefore, experiments will define how brain-derived metabolites support GBM through three specific aims. The
first aim is mechanistic and will use in vitro models to determine how metabolite exchange between normal brain
and cancer cells promotes GBM growth and survival after therapy. The second aim will investigate how tumor
metabolism and growth/survival are impacted in mice whose cortical astrocytes fail to supply specific metabolites
to GBM. The third aim will assess the therapeutic promise of pharmacologically antagonizing these processes
in intracranial GBM models, laying the groundwork for clinical studies targeting glutamine and lactate in patients.
The mentored K99 phase of this program will be overseen by Drs. Daniel Wahl and Jack Parent at the
University of Michigan. In addition, Drs. Theodore Lawrence (University of Michigan), Maria Castro (University
of Michigan), Costas Lyssiotis (University of Michigan), and Nathalie Agar (Harvard Medical School, Brigham
and Women’s Hospital) will serve as a postdoctoral advisory committee. Together, the applicant and mentorship
team have established a career development plan employing exceptional resources at the University of Michigan
focused on neuroscience and tumor microenvironment, collaboration, grantsmanship, presentation, mentorship,
and management skills for the applicant to lead a successful and productive independent research program.

Public health relevance
Project Narrative Glioblastoma (GBM) is the most common type of invasive brain tumor and uniformly fatal due to therapeutic resistance. I have found that this resistance is due in part to aberrant metabolic activity, including an ability of GBMs to use astrocyte-derived glutamine and lactate to promote their own growth and therapy resistance. The project outlined in this proposal will investigate how GBMs use the brain microenvironment to their own metabolic benefit and is particularly relevant to ongoing clinical efforts targeting metabolism in patients with GBM.